Urokinase-type plasminogen activator in the ischemic brain

? DESCRIPTION (provided by applicant): Urokinase-type plasminogen activator (uPA) is a serine proteinase that binds to the urokinase plasminogen activator receptor (uPAR). Although it was initially believed that the main role of uPA-uPAR binding was to catalyze the conversion of plasminogen into plasmin on the cell surface, it was soon discovered that uPAR also activates cell signaling pathways in response to changes in the composition of the extracellular matrix (ECM) leading to tissue remodeling, wound healing, and cell adhesion and migration. uPA and uPAR are expressed in cerebral cortical neurons in the adult brain. In this application we will test the hypothesis that binding of uPA to uPAR in the area surrounding the necrotic core promotes dendritic spine recovery and functional improvement after an ischemic stroke.

Public health relevance
PUBLIC HEALTH RELEVANCE: The interruption of the blood supply to the brain causes the death of brain cells (neurons) that results in the loss of function carried over by them. However, during the recovery phase from an ischemic stroke the neurons that survive take over the function of those lost to the stroke. In this application we will study the mechanism whereby neurons re-connect to assume new functions and how this process leads to neurological recovery after stroke.